Let-7b in BPD

Project Summary
Bronchopulmonary dysplasia (BPD) is common in extremely low birth weight (ELBW) infants.
Recently, we discovered that the strongest biomarker signal was of microRNA let-7b-5p, with a 46-fold
increase (p<0.001) at birth in the blood of infants who subsequently developed severe BPD (versus
no BPD) many weeks later at 36w post-menstrual age. We also found a 14-fold increase of let-7b-5p on day
1 in the tracheal aspirate of infants who subsequently developed BPD. In cell culture, airway epithelial cells
were the primary source of let-7b-5p, that increased with hyperoxia. We found that excessive let-7b inhibits
angiogenesis, and that let-7b inhibition during hyperoxia improves lung development in newborn mice.
In the “Let-7b in BPD” project, we will build upon our exciting discovery of let-7b-5p as a robust
biomarker of BPD, and determine its relevance to lung development and BPD. We will test the central
hypotheses that miRNA let-7b-5p is (a) a valuable biomarker for staging, monitoring disease
progression and response to therapy, (b) is released from airway epithelial cells by oxidative stress,
(c) is a contributor to dysregulated angiogenesis in bronchopulmonary dysplasia, and (d) that
inhibition of let-7b signaling improves lung angiogenesis and attenuates the BPD phenotype.
We will test the hypotheses by the following Specific Aims:
Specific Aim 1 – Determine if plasma let-7b-5p concentrations in extremely preterm infants track with lung
disease progression and correlate with response to therapy.
Let-7b-5p will be measured in serial plasma samples from a well characterized prospective cohort of
150 extremely preterm infants. We will define the temporal changes in let-7b-5p with respiratory illness
severity, BPD staging and lung mechanics at 36w PMA, and with clinical therapies.
Specific Aim 2 – Determine the mechanisms of Let-7b release by newborn mouse lung airway epithelium
To confirm that the let-7b-5p release by oxidative stress is the key upstream mechanism, we will use
novel transgenic mice. We will test the hypothesis that reduction of mitochondrial ROS reduces let-7b-5p
and the BPD phenotype, and determine the role of Nrf2 and NF-kB signaling using specific
inhibitors/modulators in cell culture models.
Specific Aim 3 – Determine effects of excessive let-7b-5p signaling on lung microvascular development.
We will test the hypothesis that over-expression of let-7b-5p induces impaired lung microvascular
development, inducing a BPD phenotype in newborn mice even in normoxia, and that inhibition of let-7b-5p
improves lung development in hyperoxia- exposed newborn mouse lung (BPD model).

Public health relevance
Project Narrative: Bronchopulmonary dysplasia (BPD) is a common lung disease in premature babies. We discovered that increases in the microRNA let-7b-5p as early as birth strongly predict which infants will later develop BPD. In this project, we will find out if increases in this microRNA in human preterm infants at later time points is also predictive, and we will use mouse models and cell cultures to see if this microRNA is increased by oxygen exposure and causes BPD by decreasing blood vessels in the lung.